Michigan Center for Urban African American Aging Research

OVERALL ABSTRACT
The Michigan Center for Urban African American Aging Research (MCUAAAR), a center comprised of the
three Research 1 universities in Michigan, proposes to expand its reach and impact by mentoring junior faculty
(most of whom are African American) and by focusing on the unique aspects of stress and coping in older
African Americans using a life course lens. Our four specific aims include (1) Increase reach through the
maturation of our three-university structure and our growing relationships with five HBCUs; (2) Recruit and
mentor 15 new junior researchers whose research will focus on health disparities and unique life course
experiences of stress and coping in African American older adults; (3) Enhance our established nationally
recognized model for successfully engaging with urban African American communities; and (4) Continue to
build the next generation of leaders for MCUAAAR. Three cores (LAC, AnC and CLRC) and the Research
Education Component (REC) are proposed in this application. We will employ an integrative approach to
mentoring, entailing a structured set of activities and training across the pilot funding period:(a) Formal goals
will be set at the beginning of the pilot and reviewed in monthly MCUAAAR meetings; (b) Based on the goals
set, a mentoring team will be assembled to assist with research, dissemination of findings, and research
translation;(c) A set of training activities in scientific writing, measurement, and community-based research
partnerships will be conducted each year; (d) A formal six and twelve-month evaluation will be conducted and
shared with the MCUAAAR faculty. We continue to be motivated by the dearth of NIH studies in health
disparities and by the continued low representation of African Americans funded through R01 grants. The
RCMAR program has been important in helping to eliminate this gap for RCMAR researchers overall.

Public health relevance
PROJECT NARRATIVE: OVERALL The purpose of the MCUAAAR is to recruit, mentor, and develop the next generation of diverse NIH researchers engaged in research on the science and amelioration of health inequities and disparities among African American older adult populations, and to engage the community of African American older adults in new ways to promote research participation.